PREVENTING STRUCTURAL DETERIORATION IN RENAL ALLOGRAFTS

We propose that nutrition intervention and physical activity will decrease the amount weight gained, the amount of protein consumed, dyslipidenias, hypertension, and hyperinsulinemia and affect the incidence of progressive fibrosing and atherosclerotic lesions in the renal allograft.